National Consortium on Alcohol and NeuroDevelopment in Adolescence (NCANDA): Administrative Resource

ABSTRACT
The purpose of this Administrative Supplement is to request additional funds for meeting the aims of the
Administrative Resource (AR U24 AA021695) of the National Consortium on Alcohol and Neurodevelopment in
Adolescence - Adulthood (NCANDA-A), specifically by providing clearly defined and well-organized non-imaging
data to share with the scientific community through the National Data Archive (NDA). The goals and objectives
of the NCANDA AR are to ensure the success of the consortium. The NCANDA-A consortium includes an
Administrative Resource (UCSD), a Data Analysis Resource (SRI), and five cross-national Research Project
Sites located at Duke University (Duke), Oregon Health Science University (OHSU), University of Pittsburgh
(Pitt), SRI International (SRI), and UC San Diego (UCSD). Monitoring has involved annual multimodal
neuroimaging (MRI, DTI, resting state fMRI, task fMRI), cognitive, clinical, behavioral, and biological data,
collected in person or remotely by computer and our mobile app. These measures will now be complemented
with new advanced neuroimaging, sleep data, and physical activity tracking. Our accelerated longitudinal design
uniquely positions NCANDA-A (ages 18-34) to quantify transient and enduring alcohol-related disturbances in
adolescent and early adult neural system growth trajectories and functional concomitants. This supplement will
provide the resources needed to archive existing NCANDA data collected using digital technologies collected at
a higher time resolution than most of the NCANDA data. Specifically, NCANDA developed a mobile phone
application called mNCANDA to assess alcohol, other substance, mood, and behavior data several times per
day in weeks preceding annual brain scans, and weekly throughout the year. NCANDA now has 5 years of data
ecological momentary assessment (EMA) data collected via mNCANDA as well as 6 months of Fitbit data
collected as well as ongoing collection underway with both. This 1-year supplement will provide the expertise
and person power needed to (1) organize these data forms to provide summary variables that time-lock with
other NCANDA data, and (2) curate the raw mNCANDA data that can be shared and used meaningfully by the
scientific community. This will be done for all available data from all 831 NCANDA participants at NCANDA’s 5
sites.

Public health relevance
PROJECT NARRATIVE The purpose of this Administrative Supplement is to support the aims of the Administrative Resource (AR U24 AA021695) of the National Consortium on Alcohol and Neurodevelopment in Adolescence - Adulthood (NCANDA-A), by providing clearly defined and well-organized fully de-identified data to share with the scientific community through the National Data Archive (NDA).